Systems approach to elucidate the microbiome's influence on the development of food allergies early in life

PROJECT SUMMARY
Candidate: Victoria M. Martin, MD, MPH aims to become an independent NIH-funded physician scientist and
recognized expert in systems immunology in mucosal food allergic diseases. To achieve this goal, she has
built a large prospective observational cohort designed to answer the questions posed under this award, while
obtaining a Master of Public Health degree in Clinical Effectiveness with training in epidemiology and
biostatistics. She is a pediatric gastroenterologist and Co-Director of the Pediatric Gastroenterology Section of
the Food Allergy Center at the Massachusetts General Hospital, and an Instructor in Pediatrics at Harvard
Medical School. She has a strong research foundation but requires substantial advanced training in three key
areas: (1) Integrated Longitudinal Microbiome Analyses, (2) System Immunology with Advanced
Computational Modeling, and (3) Clinical Research Methods and Leadership Development. Her training
objectives and research posed under this award are aimed to prepare her for her first R01 application and will
allow her to develop her own distinct niche in integrated systems biology of gastrointestinal food allergy.
Research: Food allergy is a potentially life-threatening disease with increasing prevalence in children for which
the biological explanation remains unclear, but the role of the microbiome and mucosal immune system are
being investigated. Food protein-induced allergic proctocolitis (FPIAP) is often the earliest and most common
manifestation of food allergy and yet little is known about its pathophysiology or its relationship to other food
allergic diseases, making it an important model for prospective study. This proposal outlines a five-year
research plan using a large observational cohort carefully designed by Dr. Martin to investigate the hypotheses
that (1) a dysbiosis in the intestinal microbiome of infants with FPIAP precedes disease onset, is influenced by
diet, and drives pathways of intestinal inflammation; and (2) FPIAP is a first step on the atopic march and the
underlying FPIAP pathophysiology and dietary avoidance together increase risk for IgE-FA. This proposal aims
to elucidate underlying mechanisms for the earliest manifestations of food allergies, validate novel biomarkers
of food allergy development, and identify important novel targets for primary food allergy prevention.
Environment: Dr. Martin will conduct this research at Massachusetts General Hospital, under the duel
mentorship of Dr. Wayne Shreffler, a thought leader in the field of pediatric food allergy and immune tolerance
research, and Dr. Alessio Fasano, a world-renowned expert in the microbiome and gastrointestinal physiology.
She has assembled a training advisory committee of experts in mucosal immunology (W. Allan Walker, MD),
food allergy epidemiology (Corinne Keet, MD, MS, PhD), systems immunology (Jessica Lasky-Su, ScD), and
computational microbiome analysis (Vanni Bucci, PhD; Moran Yassour, PhD). The combination of this
exceptional mentorship and advisory team and expansive resources at Harvard University will ensure her
success in transitioning to independence in an area distinct from each of her mentors.

Public health relevance
PROJECT NARRATIVE Food allergy prevalence in children is dramatically rising and can be life-threatening while the biological explanations remain unclear. Utilizing a large prospective longitudinal healthy infant cohort I built to identify pediatric mucosal and allergic diseases, I propose to study the role of the intestinal microbiome in the development of one of the earliest manifestations of food allergy in children. Integrated analyses of comprehensive prospective clinical metadata, dense longitudinal biological sampling, and carefully defined allergic outcomes will allow us to identify important microbial and inflammatory pathways and immunologic responses, useful biomarkers, and novel targets for food allergy prevention.